Spatial genomics analysis of tumor samples

SUMMARY
Imaging the tumor microenvironment (TME) is key to understanding tumor growth, disease
progression and therapy options. The TME often consists of a complex neighborhood of diverse
populations of immune cells, fibroblasts, and tumors cells. Little is known about the “geography”
of the tumors and the spatial organization of the distinct cell types. The ability to rapidly identify
different cell types and tumor subtypes using molecular markers will be transformative for cancer
diagnostics.
At Spatial Genomics, we are commercializing technology that allows transcript profiling in tumor
samples. With this technology, cell types in situ and spatial organizations can be directly identified
and visualized in tumor tissue slices. These capabilities provide a powerful tool for examining the
different cell types and their interactions in the tumor microenvironment. In this proposal, we will
develop the reagents, instrumentation, and the associated software that will allow researchers to
perform spatial mapping experiments in tumor slices.

Public health relevance
NARRATIVE Understanding cell-to-cell interactions in tumors is critical for clinical diagnostics and medical research. Spatial Genomics has developed a technology to map cell populations and molecular states of single cells in the native tumor microenvironment. This technology can identify cell types and the spatial interactions between immune cells and tumors cells in the tissue to generate a spatial map with molecular information.